Dietary alteration of n-6 and n-3 fatty acids for chronic low back pain

ABSTRACT
The NIH has declared that developing new non-addictive treatments for chronic pain is one of its top priorities.
Certain polyunsaturated fatty acids are precursors to oxylipins that regulate pain pathways. Oxylipins derived
from omega-6 (n-6) linoleic acid tend to have pro-nociceptive properties, while oxylipins derived from omega-3
eicosapentaenoic acid (n-3 EPA) and docosahexaenoic acid (DHA) tend to have anti-nociceptive
properties. Because humans cannot synthesize n-3 and n-6 fatty acids de novo, the levels of these fatty
acids—and their oxylipin derivatives—can be altered by diet. We have published results of two randomized
controlled trials testing targeted dietary modification of n-3 and n-6 fatty acids (H3L6 diet) among adults with
chronic headache (n=67) and migraine (n=182) reporting reductions in headache of 25-40% and reduction in
NSAID use. The H3L6 diet altered the concentration of circulating n-6 and n-3 fatty acids and their oxylipin
derivatives, and these changes predicted improvement in headache. These results suggest that the H3L6 diet
is a promising adjunct treatment for reducing headache and a useful model for investigating mechanisms of
pain reduction. Preclinical studies suggest that oxylipin modification could be efficacious in other chronic pain
conditions characterized by neuronal sensitization and inflammation, but this has not been demonstrated in
humans. We have pilot data (n=40) supporting feasibility and reduced pain intensity in adults with chronic
lumbosacral radiculopathy randomized to the H3L6 vs control diet. We propose to conduct a 16-week
randomized controlled trial testing the efficacy and biochemical mechanisms of the H3L6 diet among adults
receiving usual care for chronic axial low back pain. We hypothesize that increasing dietary n-3 EPA+DHA
while lowering n-6 linoleic acid will alter nociceptive oxylipins in a manner that decreases the intensity of back
pain as well as pain medication use. The goal of this R34 planning grant is to develop all the necessary
documents and procedures to conduct that trial. In Aim 1, we will update the H3L6 and control interventions to
current nutrient values since the food supply has changed since they were developed. In Aim 2, we will
complete all the planning activities (e.g., preparation of the manual of operating procedures, development of
informed consent forms, and develop safety and data management plan) that are critical prior to implementing
a clinical trial. Completion of this aim will take care of all requirements in the NIAMS Clinical Trial Planning
Milestone Checklist and will facilitate the launching of a trial that is hypothesis-driven and milestone-
defined. The proposed project is part of a series of studies designed to translate the preclinical and clinical
research on oxylipin-pain pathways into accessible, effective, non-addictive treatments for chronic pain. Based
on our previous work, this approach of using dietary modifications to alter biochemical regulators of chronic
pain is a low-risk, high-reward endeavor potentially leading to new treatment options and biomarkers of
treatment response.

Public health relevance
PROJECT NARRATIVE Chronic pain afflicts millions of people, and many treatment options have serious side effects. A diet-based approach has shown promise in regulating pain signaling mechanisms and decreasing pain. The purpose of this grant is to develop a clinical trial to test whether and how this diet-based approach reduces pain in adults with chronic low back pain.